The role of anaerobic microbiota in cystic fibrosis airway disease trajectory

PROJECT SUMMARY / ABSTRACT
Despite the recent surge in studies reporting on the prevalence and abundance of anaerobic
microbiota in the airways of individuals with cystic fibrosis (CF), their mechanistic contributions, if any, to
disease pathophysiology remain controversial and poorly understood. This knowledge gap is driven, in
part, by conflicting epidemiological and in vitro experimental data, a lack of suitable model systems to study
their interactions with the host, and the dearth of laboratory expertise in host-associated anaerobic
microbiology. Studies that generate greater insight into the role of anaerobes in CF lung infection,
particularly at early stages, are necessary to determine if, when, and how to target this group of organisms
therapeutically.
Our team has shown that (i) anaerobes are early colonizers of the pediatric CF airways prior to the
acquisition of canonical pathogens, (ii) anaerobe bacterial communities elicit pro-inflammatory response
when co-cultured with bronchial epithelial cells, and (iii) anaerobe-mediated mucin degradation and cross-
feeding can shape the growth, virulence, and antibiotic susceptibility of canonical CF pathogens. Building
on these data, this project proposes to use a multi-disciplinary approach to investigate how individual
anaerobes interact with one another, the airway epithelium, and traditional pathogens (e.g., P. aeruginosa,
S. aureus) in the context of early CF airway disease. First, using an experimental microbiome model
system composed of 10 CF anaerobic species, we will determine how CF bacterial communities assemble
and how their assembly dynamics are shaped by host and microbial processes. Second, using an
innovative dual oxic-anoxic system that enables co-culture of anaerobic bacteria and airway epithelial cells,
we will use single-cell RNA sequencing to determine how anaerobes interact with the airway epithelium,
and how the host response varies by epithelial cell type. Finally, given that P. aeruginosa, S. aureus, and
other aerobic pathogens co-colonize with anaerobic microbiota and rapidly adapt to the airways as patients
age, we will use an in vitro experimental evolution approach to test whether early CF microbiota are
sufficient to drive the adaptation of canonical pathogens to the nutritional milieu of the CF airways.
At the completion of these aims, we will have defined how individual anaerobes interact with one
another, the host, and traditional CF pathogens. In doing so, these studies will have a meaningful impact
on our mechanistic understanding of the role of airway microbiota in chronic airway disease and may
motivate future studies targeting specific anaerobic bacteria, or even promoting their growth, as a means
of improving clinical outcomes. Finally, we use CF as our model system, but this work is broadly applicable
to other acute and airway infections (e.g., COPD, sinusitis, ventilator associated pneumonias) in which
anaerobes have been implicated but their mechanistic contributions remain undefined.

Public health relevance
PROJECT NARRATIVE Culture-independent sequencing has revealed that strict and facultative anaerobic bacteria are both prevalent and abundant in in the CF airways, but their mechanistic contribution(s) to disease pathophysiology and long-term clinical outcomes are poorly understood. The focus of this project is to define how individual anaerobes interact with one another, the host, and traditional CF pathogens and to test our hypothesis that anaerobic microbiota set the stage for consequent disease trajectories. By understanding how anaerobes contribute to the development of early CF airway environment, we can identify new therapeutic strategies for more effective disease management and improved long-term patient outcomes.